COVID Supplement B Cell Epitope Discovery and Mechanisms of Antibody Protection.

This contract supports the identification of human B cell epitopes derived from viral pathogens; such as Coronavirus, Dengue virus 4, Powassan virus, Chikungunya virus, and Venezuelan equine encephalitis virus, combined with basic studies to understand protective immunity mediated by antibodies, as well as pathological consequences of antibody responses.